Development of a therapeutic nanobody targeting brain TNFa for the treatment of Alzheimer Disease

Abstract:
This project seeks to advance the development of humanized TNFα inhibitors (INNs) as a novel
therapeutic approach for Alzheimer's disease (AD). Our innovative INNs are designed to
effectively inhibit TNFα while crossing the blood-brain barrier, targeting the neuroinflammatory
processes central to AD pathology. Building on Phase I achievements, which included
identifying INNs with high TNFα inhibitory activity and favorable blood-brain barrier permeability,
Phase II will focus on rigorous preclinical evaluations in human-induced neurons, App-
humanized rats, and familial and late-onset AD rat models. We will optimize INN formulations,
characterize pharmacologic and toxicologic parameters, assess their immunogenicity, and begin
establishing manufacturing processes for IND filing and clinical development. The success of
this project could lead to a transformative treatment for AD, addressing a critical unmet need in
neurodegenerative disease management.

Public health relevance
Project Narrative Neuroinflammation, microglia dysfunction and supraphysiological TNFα activity have been implicated in sporadic late onset Alzheimer Disease (LOAD) pathogenesis but, unfortunately, FDA-approved inhibitors of TNFα are large molecules that have limited blood-brain barrier penetration. During the Phase I STTR grant studies, we generated inhibitors of TNFα that penetrate efficiently the Blood-Brain-Barrier and that could block supraphysiological TNFα activity in the Central Nervous System (TNFI-Nab) as therapeutic agents to prevent, arrest or reverse LOAD. Given that there is no cure for LOAD, that ~5.4 million Americans have LOAD and that without disease-modifying therapeutics this number is expected to triple in 2050, this study addresses a critical medical area with a pressing need for therapeutic advances.